Career Training in Reproductive Biology

Abstract
Reproductive health is the window to overall health and offers enormous opportunities and challenges for high-
quality interdisciplinary research and careers. The goal of this renewal is to continue the efforts of the Career
Training in Reproductive Biology (CTRB) Program to train exceptional predoctoral students for diverse
scientific careers in the reproductive sciences. Funds are requested to train five predoctoral students per year
in a dual program consisting of two main parts. First, to prepare for a research career, students will engage in
rigorous, hypothesis-based scientific laboratory work in reproductive biology. Second, to prepare students for
varied career paths, they will complete a University of Michigan-sponsored Certificate program or other
structured career development activities to hone skills in teaching, translational research, public policy,
biotechnology, entrepreneurship, biotechnology or other areas of their choosing. These career development
programs were specifically designed to dovetail with graduate work to prepare students with the qualitative and
quantitative skills needed for careers in specific disciplines. This innovative program addresses the needs of
reproductive biology trainees in a way unlike any other program at the University of Michigan. Fourteen select
faculty mentors, who are highly recognized scientists with a passion for and extensive combined experience in
predoctoral education, enthusiastically comprise the CTRB Program faculty. Trainees are drawn from
exceptionally strong graduate programs in biomedical sciences, biomedical engineering and environmental
health sciences. Specific training activities include formal courses in Mammalian Reproductive Physiology,
Scientific Communication and Responsible Conduct of Research, and statistical analyses/experimental design,
participation in a mentoring workshop with their preceptor, monthly mentored trainee research presentations,
group discussions of laboratory management, expanded ethics training in reproductive research, two annual
symposia in reproductive sciences and twice-yearly mentoring meeting. Trainee input has and will continue to
actively shape the training program. Trainees and mentors submit formal competitive applications that are
reviewed and required for appointment to the CTRB Program. The CTRB Program is monitored through active
engagement of faculty and trainees in program development, and by an experienced internal advisory
committee. These mechanisms ensure program responsiveness to demands of a continuously evolving
research environment and changing trainee needs.